Alzheimer’s Disease Related Biomarkers following SARS-CoV-2 Infection

ABSTRACT
Cognitive impairment is a major symptom among patients with post-acute sequelae of COVID-19. Older
individuals and those with dementia risk factors are particularly at risk. In our own prospective study of 4,491
hospitalized COVID-19 patients, the median age was 65 years, 606 (14%) developed new neurological disorders
(most commonly encephalopathy) during hospitalization, indicating a population at high risk for development of
Alzheimer’s Disease or Related-Dementia (AD/ADRD). Of this group, 48% of patients who were cognitively
normal pre-COVID had abnormal telephone MoCA scores (<18) 6-months post hospital discharge. We identified
significant elevations in plasma biomarkers of neurodegeneration/AD including total tau, p-tau-181, UCH-L1,
neurofilament light chain (NfL) and GFAP in hospitalized COVID-19 patients who developed encephalopathy
compared to those who did not. These biomarkers significantly correlated with IL-6, CRP, ferritin and D-Dimer
measures of inflammation. We hypothesize that older subjects with COVID-19, in particular those with
new post-COVID subjective or objective cognitive abnormalities, will have increased plasma and
radiographic AD/ADRD biomarkers, and a greater likelihood of abnormal cognitive testing and
progression to Alzheimer’s disease or related dementias over time. We will enroll 3 groups of patients aged
≥60 years including: 1) SARS-CoV-2 positive subjects who have a new subjective or objective cognitive
symptoms ≤6 month from index SARS-CoV-2 infection (COVID+Cog+) 2) SARS-CoV-2 positive subjects without
subjective or objective cognitive symptoms ≤6 month from infection (COVID+Cog-); and 3) SARS-CoV-2
negative, neurologically/cognitively normal subjects, enrolled in the NYU ADRC Clinical Core (Controls). We will
exclude individuals with a history of MCI or AD/ADRD prior to SARS-CoV-2 infection. Our primary outcome will
be the differences in trajectories of global cognition/function (Clinical Dementia Rating Scale Sum of Boxes
[CDR-SB]) over the 5-year study across the 3 groups. Secondary outcomes will include: differences in plasma
and radiographic AD/ADRD biomarkers over time compared across the 3 groups. Aim 1: Characterize and
compare cognitive and neuropsychological abnormalities at enrollment and over time (every 12 months), among:
COVID+Cog+, COVID+Cog- and controls using the CDR-SB, and Uniform Data Set Version 3. Aim 2:
Characterize and compare plasma AD/ADRD-related biomarkers of neurodegeneration, inflammation and BBB
dysfunction at enrollment and over time (every 12 months), among COVID+Cog+, COVID+Cog- and controls.
Aim 3: Characterize and compare AD/ADRD neuroimaging biomarkers in COVID+Cog+, COVID+Cog- and
controls at enrollment and over time (every 18 months) using 3T MRI. Collectively, these studies will elucidate
predisposing risk factors and biomarkers for COVID-related cognitive abnormalities, provide mechanistic insights
into underlying pathogenesis, and provide data on long-term outcomes, including the development of AD/ADRD-
related disorders.

Public health relevance
We hypothesize that older subjects with COVID-19, in particular those with new post-COVID subjective or objective cognitive abnormalities, will have increased plasma and radiographic AD/ADRD biomarkers, and a greater likelihood of abnormal cognitive testing and progression to Alzheimer’s disease or related dementias over time. Our proposed studies will elucidate predisposing risk factors and biomarkers for COVID-related cognitive abnormalities, provide mechanistic insights into underlying pathogenesis, and provide data on long- term outcomes, including the development of AD/ADRD-related disorders.